Next generation Magnetoencephalography for human social neuroscience

PROJECT SUMMARY
This proposal develops the next generation magnetoencephalography (MEG) for human social neuroscience by
combining the latest available technology in optically-pumped magnetometers (OPMs) and magnetically
shielded rooms (MSRs). Successful completion of the proposed research and development will enhance MEG's
ease of use to enable the first ever 2-person face-to-face MEG recordings of social interactions. Motivated by a
pressing need to improve the relevance of human neuroimaging - which includes upright, social movement -
scalp-based sensors represent the most promising set of technologies that are both available now and are also
expected to enjoy major improvements over the next several decades. While electroencephalography (EEG)
and functional near-infrared spectroscopy (fNIRS) are currently capable of such recordings, both suffer from
limitations that would be complimented or ameliorated by “untethered” MEG. Within this context, the research
objectives of this proposal are threefold. First, Aim 1 integrates the latest generation of OPM sensors and MSR
technology to deliver a next generation platform for OPM-MEG experiments. These data, then provide a positive
control to use this system for multi-person, movement tolerant neuroimaging in Aim 2. Finally, in Aim 3 we will
evaluate sensor mounting strategies and source reconstructions strategies that will avoid obscuring parts of the
face and could reduce cost and improve experimental ease. The work proposed will conducted by an assembled
team of the world's leading academic and industry experts in OPM-MEG, magnetic shielding, social
neuroimaging, and neuroimaging data analysis.

Public health relevance
PROJECT NARRATIVE This proposal combines the latest available technology in optically-pumped magnetometers (OPMs) and magnetically shielded rooms (MSRs) to develop OPM-MEG as a next-generation tool for human neuroscience. Neurological disorders and psychiatric disease are of the utmost clinical importance, but there is currently a pressing need to develop technologies to improve the relevance of human neuroimaging. The technological developments proposed here will enhance MEG's ease of use to enable the first ever simultaneous, in person MEG recordings of social interactions.